Harnessing the genetics of chronic pain to inform the development of non-additive analgesic medications

Project Summary/Abstract
Chronic pain is a major health burden and constitutes the greatest cause of years lived with disability. Current
treatment options for pain are largely non-specific and often have clinically significant adverse effects, poor
efficacy in many patients, and addictive potential. A greater understanding of the molecular mechanisms
underlying chronic pain is critical to enable identification of novel or repurposed analgesics that are safe and
effective. Chronic pain has a substantial genetic component and efforts to inform drug development using
genetics are more than twice as likely to yield medication approvals. However, the genetic mechanisms
associated with chronic pain are not well understood and studies are limited by a near-exclusive focus on
individuals of European ancestry. The principal investigator, Dr. Sylvanus Toikumo, recently conducted the
largest multi-ancestry genome-wide association study (GWAS) of pain intensity (N = 598,339) to date, which
identified 125 independent genetic loci. This proposal capitalizes on findings from that GWAS and enables Dr.
Toikumo to acquire methods and skills to elucidate the genetic risk for chronic pain, and potentially help to identify
new analgesic medications. Training opportunities linked to each of the specific aims will enhance Dr. Toikumo's
development as an independent investigator. Aim 1 will characterize the genetic architecture underlying chronic
pain liability and addiction, which he will achieve by using a) genomic structural equation modeling to derive a
common genetic liability factor for pain from the multi-ancestry GWAS of pain intensity and other pain related
GWASs b) multivariate GWAS meta-analysis of the chronic pain factor and c) analyses of the unique and shared
genetic architectures of pain and addiction risk. Aim 2 will estimate the causal effect of brain and plasma proteins
and curate drug targets for causal proteins in silico using drug databases. Aim 3 will use gene mapping to
integrate existing GWAS data with functional genomic annotations in ATAC-seq and high-resolution genome-
wide promoter-focused Capture C/Hi-C data from human iPSC-derived cortical neurons to identify effector
genes. Aim 4
developing
mechanistic to identify novel treatments.
Specifically, the K99/R00 Pathway to Independence award will provide Dr. Toikumo with training in pain
phenotyping, statistical genetics, computational genomics, and gene mapping techniques. These training
objectives will be supported by Drs. Kranzler, Kember, Grant, Gandal, Diatchenko, Farrar, Cheatle, and Corder
and the technical and intellectual resources of the University of Pennsylvania, the Children's Hospital of
Philadelphia, and a yet-to-be determined research institution. Together, the proposed scientific aims and training
objectives will form the foundation for an independent research program aimed at identifying risk mechanisms
and novel medications for chronic pain.
will rioritize risk genes and pathways underlying genomic regulation using i so-QTL data from
human fetal brain tissues. Together, these aims will elucidate t he genetic architecture and
underpinnings of chronic pain and inform translational models
p

Public health relevance
Project Narrative Chronic pain is common in the United States and currently available treatments are nonspecific, of limited efficacy, and characterized by substantial addictive potential. The findings of this study will significantly advance our understanding of the shared genetic architecture of chronic pain and addiction, paving the way for the development of safe, non-addictive analgesics. The proposal is relevant to NIDA's mission to develop effective treatments for pain through genetic research and will provide the principal investigator with important mentorship and training opportunities to enable him to develop an independent research career.